Investigating the Cellular Impact of 8-oxo-Guanine on DNA Replication and Genome Stability

Project Summary/Abstract
Excess reactive oxygen/nitrogen species, or oxidative stress, is a ubiquitous condition humans experience that
can damage the entire cell. Importantly, oxidative stress damages DNA resulting in numerous lesions that can
halt DNA replication and increase mutagenesis. Oxidative stress emanates from various endogenous sources
(metabolism, inflammation, etc.) but also exogenous environmental sources such as pollution, smoking, and
solar ultraviolet radiation (UVR), arguably the most universal source of oxidative stress and DNA damage
humans encounter. 8-oxo-deoxyguaine (8oxoG) is one of the principle adducts generated by oxidative stress,
and while well studied in vitro, is historically difficult to investigate in cells since the agents used to produce it
(UVA, hydrogen peroxide, etc.) also generate other DNA adducts, strand-breaks, and damage lipids and proteins
throughout the cell. Our group has developed and published on a novel fluorogen activated peptide (FAP) which
can bind malachite green photosensitizer dyes and when excited with far-red light, specifically produces singlet
oxygen. Singlet oxygen is known to have a short half-life and reacts rapidly with guanine to form 8oxoG. By
fusing FAP to the telomere binding protein TRF1, we were able to demonstrate the specificity of our
chemoptogenetic system, and its spatial and temporal control. We have also generated cell lines which express
FAP fused to the histone H2B (H2B-FAP), allowing for genome-wide production of 8oxoG. The overall hypothesis
of this proposal is that 8oxoG stalls DNA replication forks, especially at repetitive DNA sequences like telomeres,
requiring the activities of ATR, Pol η, and PrimPol. This proposal is uniquely poised to address this hypothesis,
as the H2B-FAP and TRF1-FAP tools are the only methods available to specifically induce 8oxoG within the
human genome. In addition to telomeres, use of the H2B-FAP tool will allow for the identification of other
sequences sensitive to 8oxoG formation by examining the binding of replication stress response factors by ChIP-
seq. Using physiological conditions, these identified sequences as well as telomere repeats will be studied in
vitro to determine if they stall replicative DNA polymerases. This combination of biochemical and cellular
replication studies will fill a critical gap in our knowledge of how 8oxoG impacts replication fork integrity
and cell fate. Oxidative stress is linked to various diseases including cancer, but also aging. However, due to
its pleiotropic effects, it is difficult to attribute any specific outcome to a particular lesion. While this study will
advance our general understanding of 8oxoG, it will directly compare H2B-FAP activation with UVA (a specific
subset of UVR), which induces pyrimidine dimers in addition to oxidative stress. UVR promotes skin
carcinogenesis especially in the absence of factors such as Pol η, the protein mutated in the cancer
predisposition syndrome, XPV. This study will also examine the direct role of Pol η and other DNA replication
factors (ATR, PrimPol, FANCD2, and MacroH2A1.2) in the cellular response to 8oxoG.

Public health relevance
Project Narrative Oxidative stress is a ubiquitous source of DNA damage that humans experience emanating from endogenous and exogenous agents such as solar ultraviolet radiation, which produces singlet oxygen. Our group has developed a tool to specifically induce singlet oxygen mediated base damage in human cells specifically at telomeres or throughout the genome. This proposal will utilize these tools as well as UVA irradiation to study the specific impact of the lesion 8-oxo-guanine on replication fork progression in vitro and in cells, and the resulting consequences on genome stability, cell death, and senescence.